Neural mechanisms of motivational and cognitive impairment in opioid withdrawal

Summary
The opiate epidemic has led to a surge in overdose deaths and significant societal and economic costs. Opiate
withdrawal poses obstacles to recovery by causing emotional, motivational, and cognitive disturbances that
disrupt one’s ability to pursue adaptive goals. Understanding the neural mechanisms underlying these
withdrawal-induced deficits may facilitate strategies to promote abstinence. Our preliminary research shows that
rats experiencing acute morphine withdrawal exhibit reduced motivation and impaired cognitive, goal-directed
control over their actions. This project will test the innovative hypothesis that opioid withdrawal-induced
motivational deficits are mediated by opposing adaptations in dopamine (DA) and acetylcholine (ACh) release
in the nucleus accumbens (NAc) and that withdrawal-induced deficits in goal-directed action selection result from
aberrant DA and ACh signaling in the dorsomedial striatum (DMS). We will also investigate whether dysregulated
D1- and D2-striatal projection neuron (SPN) activity in the NAc and DMS contributes to withdrawal-induced
deficits in motivation and action selection, respectively. Aim 1 will combine sophisticated behavioral analysis,
quantitative no-net-flux microdialysis, and fiber photometry to determine the impact of acute and protracted
morphine withdrawal on tonic and phasic DA and ACh release and D1/D2 SPN calcium activity in the NAc and
DMS, and how these effects relate to deficits in motivation and action selection. Aim 2 will test whether these
behavioral deficits can be ameliorated, exacerbated, and mimicked through cell-type and region-specific
chemogenetic and optogenetic manipulations of striatal DA and ACh release and D1/D2 SPN activity. The study
aims to uncover novel neurochemical and neurocircuit mechanisms contributing to anhedonia-like symptoms in
morphine withdrawal, guiding future strategies to combat opioid use disorder.

Public health relevance
Narrative The opioid epidemic has led to a dramatic increase in overdose deaths and poses significant challenges for individuals who have become opioid-dependent. Our research aims to understand how withdrawal from opioids affects brain chemicals and circuits that control motivation and goal-directed decision-making. By unraveling these processes, we hope to develop new strategies to support recovery and improve treatment outcomes for those struggling with opioid-dependence.